Examining emotion regulation processes in social anxiety from an interpersonal and observational perspective

PROJECT SUMMARY/ABSTRACT
Social anxiety disorder (i.e., social phobia) is one of the most common and debilitating psychiatric disorders,
with lifetime prevalence estimates around 13% and onset peaking in early adulthood. Characterized by
excessive and persistent fear of social or performance situations, social anxiety (SA) is detrimental even in
subthreshold forms and is best conceptualized as a spectrum of symptoms and impairment. Theoretical
models and empirical research on SA converge on several key individual-level factors in the etiology and
maintenance of SA (e.g., anxious arousal and anxious apprehension regarding social contexts). However,
despite the inherent interpersonal nature of SA, there is limited focus on the processes that occur within
interpersonal interactions that can shape SA (e.g., how do friends use interactions with each other to regulate
their own and each other's social anxiety?). To address this gap, the overarching objective of the current
research is to delineate the processes within an interpersonal context that predict SA. Our central hypothesis is
that emotion emotion regulation processes occurring in social interactions (i.e., individuals' and their friends'
emotion regulation processes; e.g., co-rumination, suppression, reappraisal) will predict indicators of SA both
in the lab and daily life. To test our hypothesis, we will recruit 140 friend dyads exhibiting a range of SA
symptoms (with at least 40% meeting SA disorder threshold). In the lab, individuals will identify their most
stressful ongoing problem that involves someone outside of and unrelated to the friendship and then have a
conversation where one person discloses their problem for discussion. We will comprehensively assess
emotion regulation strategies used during the discussion using self- and partner-reports and behavioral
observations. Next, each member of the dyad will undergo a standardized social threat performance task and
dyadic pre- and post-event processes will be measured. After, participants will complete 14-day diaries for the
assessment of individual and interpersonal emotion regulation and naturally occurring internalizing symptoms
in daily life. Indicators of SA will be assessed consistent with data-driven models and in line with NIMH's RDoC
constructs of acute and potential threat, including cardiovascular (peripheral resistance) and neuroendocrine
markers (salivary cortisol), behavioral codes (e.g., performance in public speaking task), and self-reports (e.g.,
distress). Primary indicators of SA include self-reported distress and state anxiety. Findings from the current
study will build upon existing theoretical models of SA, which is crucial to laying the groundwork for developing
effective SA interventions. The central significance and innovation of the current work is to examine the
interpersonal mechanisms that may be shaping SA by directly examining dyadic interactions among close
others. This research will advance NIMH's mission to support and conduct research on mental illnesses and by
adopting a basic science approach. Finally, in line with the R15 funding mechanism, this project will provide
students with significant research experience in in psychopathology, dyadic processes, and psychophysiology.

Public health relevance
PROJECT NARRATIVE Social anxiety is a common and debilitating condition, and many individuals with social anxiety do not benefit from treatment. One barrier to understanding and treating social anxiety is the lack of research on the processes that occur within interpersonal interactions that can shape social anxiety (e.g., how do friends use interactions with each other to regulate their own and each other’s social anxiety?). Accordingly, the aims of the current proposal are to determine the extent to which individuals’ and their friends’ emotion regulation processes (i.e., co-rumination, suppression, reappraisal) predict indicators of social anxiety both in the lab and daily life.